Investigating anti-neuroinflammatory therapeutics for polysubstance use disorders

The ongoing opioid crisis, exacerbated by synthetic opioids like fentanyl, has been further complicated by rising co-use of stimulants such as methamphetamine. Despite the increasing prevalence of polysubstance use, current research largely focuses on single-drug models, limiting understanding and treatment options for polysubstance use disorders. Methamphetamine and fentanyl both induce neuroinflammation, but the combined effects of these co-used drugs on neuroinflammation and related behaviors remain unexplored. This project aims to address this gap by investigating the functional significance and mechanism of polysubstance-induced neuroinflammation utilizing a novel rodent model of polysubstance dependence and withdrawal using co- administered fentanyl and methamphetamine, with particular focus on the pro-inflammatory cytokine tumor necrosis factor-alpha (TNFα) and the neuropeptide hypocretin/orexin (HCRT). HCRT influences a wide array of physiological functions, including those relevant to drug dependence and neuroinflammation, although the function of HCRT in drug-induced neuroinflammation is not yet well-understood. The overarching hypothesis is that during polysubstance withdrawal, HCRT functions as a pro-inflammatory agent in withdrawal-sensitive brain regions of the extended amygdala and the dorsal hypothalamus, contributing to neuroinflammation (including increases in TNFα) associated with polysubstance dependence. Aim 1 will determine TNFα’s role in motivated polysubstance use and stress-induced reinstatement of drug-seeking using neuropharmacological techniques with a small-molecule TNFα-inhibitor. Aim 2 will define the role of HCRT signaling on polysubstance-induced neuroinflammation by measuring cytokine response to HCRT manipulations in polysubstance dependent rats. Findings from this research could significantly advance our understanding of the neuroimmune mechanisms driving polysubstance dependence and lead to the development of more effective treatments for addiction. Students will play an integral role in conducting hands-on, rigorous research as aligned with current NIH priorities and under the direct supervision of the PI and a team of collaborators.

Public health relevance
PROJECT SUMMARY/ABSTRACT The ongoing opioid crisis, exacerbated by synthetic opioids like fentanyl, has been further complicated by rising co-use of stimulants such as methamphetamine. Despite the increasing prevalence of polysubstance use, current research largely focuses on single-drug models, limiting understanding and treatment options for polysubstance use disorders. Methamphetamine and fentanyl both induce neuroinflammation, but the combined effects of these co-used drugs on neuroinflammation and related behaviors remain unexplored. This project aims to address this gap by investigating the functional significance and mechanism of polysubstance-induced neuroinflammation utilizing a novel rodent model of polysubstance dependence and withdrawal using co- administered fentanyl and methamphetamine, with particular focus on the pro-inflammatory cytokine tumor necrosis factor-alpha (TNFα) and the neuropeptide hypocretin/orexin (HCRT). HCRT influences a wide array of physiological functions, including those relevant to drug dependence and neuroinflammation, although the function of HCRT in drug-induced neuroinflammation is not yet well-understood. The overarching hypothesis is that during polysubstance withdrawal, HCRT functions as a pro-inflammatory agent in withdrawal-sensitive brain regions of the extended amygdala and the dorsal hypothalamus, contributing to neuroinflammation (including increases in TNFα) associated with polysubstance dependence. Aim 1 will determine TNFα’s role in motivated polysubstance use and stress-induced reinstatement of drug-seeking using neuropharmacological techniques with a small-molecule TNFα-inhibitor. Aim 2 will define the role of HCRT signaling on polysubstance-induced neuroinflammation by measuring cytokine response to HCRT manipulations in polysubstance dependent rats. Findings from this research could significantly advance our understanding of the neuroimmune mechanisms driving polysubstance dependence and lead to the development of more effective treatments for addiction. Students will play an integral role in conducting hands-on, rigorous research as aligned with current NIH priorities and under the direct supervision of the PI and a team of collaborators. SPECIFIC AIMS The global crisis of opioid and opioid co-involved overdose-related fatalities reached a new high in 2021, with nearly 300 drug-related deaths per day in the US, largely due to the high availability and consumption of illicitly manufactured synthetic opioids such as fentanyl. The excessive use of potent fentanyl analogs (either intentional or unknown as an adulterant) further exacerbates the devastating addiction crisis. Co-occurring opioid and stimulant use, or polysubstance use, is increasingly reported in clinical survey data, yet current research primarily targets mono-drug use in isolation, limiting the discovery of causes and interventions for polysubstance use disorders. Various drugs of abuse, including fentanyl and methamphetamine, have each been shown to increase neuroinflammation through proinflammatory cytokine signaling in the brain, including increased tumor necrosis factor-alpha (TNFα) and interleukin-1 beta (IL-1β) levels. However, the collective impact of polysubstance use on neuroinflammation has yet to be elucidated. Limited anti-inflammatory agents have been shown to reduce craving and drug-seeking, particularly for methamphetamine. Thus, it is possible that using anti- inflammatory agents may also be beneficial in treating polysubstance use disorders. The overarching goal of our laboratory is to utilize translational animal models to identify targets for the pharmacological treatment of substance use disorders. This proposal aims to elucidate role of neuroinflammation in polysubstance dependence (Aim 1) and determine a mechanism underlying drug-induced neuroinflammation (Aim 2), utilizing a rat model of concomitant fentanyl and methamphetamine drug taking. The neuropeptide hypocretin/orexin (HCRT) influences a wide array of physiological functions, including those relevant to drug dependence and neuroinflammation, although the function of HCRT in drug-induced inflammation is not yet well-understood. HCRT is suggested to be an anti-inflammatory peptide providing partial protection in some neuroimmune-mediated CNS disorders. Addiction studies demonstrate an increased number of HCRT-producing neurons following chronic opioid exposure in both humans and rodents, and higher circulating HCRT in the plasma of individuals who are recently abstinent from methamphetamine use. It is possible that HCRT is being recruited as an anti-neuroinflammatory mediator of drug-induced cytokine signaling in the brain. HCRT signaling is also crucial for the stability of arousal states that play an important role in drug- related motivation, particularly during drug withdrawal. A common comorbidity of substance use disorders is sleep dysfunction and sleep deprivation, that elevates HCRT levels, has conversely been shown to promote neuroinflammation. Thus, HCRT may have both anti- and pro-inflammatory properties; there is likely an optimal moderate level of HCRT that promotes neuronal protection, whereas excessively upregulated HCRT becomes pro-inflammatory and is no longer protective. The overarching hypothesis is that during polysubstance withdrawal, HCRT functions as a pro-inflammatory agent in withdrawal-sensitive brain regions of the extended amygdala and the dorsal hypothalamus, contributing to neuroinflammation associated with polysubstance dependence. We aim to test this hypothesis with the following aims: Specific Aim 1. To identify proinflammatory markers of polysubstance dependence and determine TNFα’s role in motivated drug use by testing 1a) the effects of chronic polysubstance exposure on neuroinflammation by measuring cytokine response (e.g., TNFα, IL-1β, etc.) in withdrawal-sensitive brain regions [i.e., central amygdala, bed nucleus of the stria terminalis, nucleus accumbens shell, and dorsal hypothalamus] in mono-drug and combined methamphetamine and fentanyl dependent rats compared to drug-naïve controls, 1b) the effects of systemic TNFα and 1c) TNFα-blockade on polysubstance self-administration and reinstatement of drug-seeking, and 1d) the effects of site-specific, small-molecule TNFα-inhibitor administration into withdrawal-sensitive brain regions on polysubstance taking and seeking. Our preliminary data confirm polysubstance-induced increases in pro-inflammatory cytokines TNFα and IL-1β in the central amygdala of polysubstance-dependent rats. Specific Aim 2. To define the role of HCRT signaling on polysubstance-induced neuroinflammation by testing the effects of chronic HCRT-receptor blockade on HCRT-1- or polysubstance-induced neuroinflammation as measured by cytokine response in withdrawal-sensitive brain regions (i.e., central amygdala, bed nucleus of the stria terminalis, nucleus accumbens shell, and dorsal hypothalamus) relative to HCRT levels. Our preliminary findings confirm increased HCRT-1 and HCRT-receptor 1 densities in the central amygdala of polysubstance- dependent rats. We predict that either too little or too much HCRT will reveal increased polysubstance-induced neuroinflammation. Impact: To adequately address current drug use trends, we aim to incorporate poly-drug use in a model of drug dependence to elucidate the role of HCRT and neuroinflammation in the neurocircuitry of polysubstance dependence. We expect to broaden our understanding of the underlying mechanisms of polysubstance dependence as they relate to neuroinflammation and identify novel anti-inflammatory therapeutics for substance use disorders. Furthermore, the proposed project will promote collaboration between faculty and students, enhancing their research skills and preparing them for careers in addiction sciences, in alignment with current NIH priorities.